A Phase 1b, Open-Label, Study of a Novel Targeted Radiotherapy in Children, Adolescents and Young Adults with Inoperable Relapsed or Refractory High Grade Glioma

ABSTRACT
There is no known cure for pediatric high grade gliomas (HGGs), meaning all patients eventually progress and
the prognosis for patients is very poor with 5 year overall survival below 20%. There is a high unmet need for
new drugs, including targeted radiopharmaceuticals, preferably with the ability to cross the blood-brain barrier
and have cancer-specific uptake, as there are no FDA approved treatments in either the 1st or 2nd line or
relapsed/refractory (r/r) setting at this time. These children are frequently treated off-label with drugs approved
for similar adult indications with little to no data to support the use in a pediatric HGG population, or are restricted
to investigational agents within clinical trials. CLR 131 is a radio-iodinated therapy comprising a core
phospholipid ether (PLE) analogue, 18-(p-iodophenyl)octadecyl phosphocholine, radiolabeled with iodine-131.
The cancer cell-selective uptake of PLEs and related lipids involves the selective insertion into lipid rafts.
Malignant cells have far greater amounts of lipid rafts than normal cells and these lipid rafts spatially organize
signalling pathways and regulate cell proliferation and survival. CLR 131 exploits the tumor-targeting properties
of PLEs to provide a targeted delivery of radiation to malignant tumor cells and minimizes radiation exposure to
normal tissues. Additionally, PLEs and CLR 131 have demonstrated the ability to cross the blood-brain barrier
and provide sufficient uptake into CNS tumors to result in improvements in progression free survival, overall
survival and response rates. CLR 131 was identified from a series of PLEs as the optimal delivery agent in rodent
models. Iodine-131 was chosen as the radioactive constituent due to its eight-day half-life and well-established
therapeutic capabilities in multiple adult and pediatric cancer types. The therapeutic hypothesis for CLR 131 is
supported by data from nonclinical studies using in vitro cancer cell lines as well as in vivo tumor bearing murine
models which include neuroblastoma, several soft tissue sarcomas and hematologic malignancies. To date, over
150 adult and pediatric patients with advanced r/r cancers have received CLR 131, as part of Phase 1 and 2
clinical trials in different types of cancers (including solid and hematological cancers), demonstrating that CLR
131 provides significant inhibition of tumor growth and an overall survival benefit over control groups. We are
proposing a multi-center, open-label, Phase 1b dose finding study evaluating intravenous administration of CLR
131 in up to 25 children, adolescents and young adults with recurrent or refractory malignant HGG at two doses
(25 children per dose group). We predict that CLR 131, in this expanded pediatric population study, will have a
similar safety profile as was observed in pediatric and adult patients with cancer dosed at similar levels. The
planned next step is a pivotal Phase 2/3 study to evaluate the efficacy of CLR 131 in children, adolescents and
young adults with recurrent or refractory malignant HGG.

Public health relevance
NARRATIVE Most pediatric patients with relapsed high grade glioma are confronted with a poor prognosis. For these patients there is currently no accepted second-line treatment regimen. There is a need for new drugs, including targeted radiopharmaceuticals, preferably with the ability to cross the blood-brain barrier and provide cancer-specific uptake.